DP21-001 Kentucky Pregnancy Risk Assessment Monitoring SystemApplication for Core PRAMS funding RFA-DP-21-001

Project Summary
The Kentucky Department for Public Health (KDPH) is applying for Component A Core
Surveillance for the Pregnancy Risk Assessment Monitoring System. This application is in
response to Notice of Funding Opportunity RFA-DP-21-001.

Public health relevance
Project Narrative The Kentucky Department for Public Health (KDPH) is seeking to conduct on-going core PRAMS surveillance among women with a recent live birth. The KDPH will conduct PRAMS surveillance according to the CDC approved PRAMS protocols and implement survey supplements to respond to emerging issues when needed.